Biology and Biotechnology of Cell and Gene Therapy

Project Summary
Graduate education has traditionally been successful in educating students in either engineering or the
biomedical sciences, but the disparate nature of the scientific and engineering backgrounds necessary to
successfully move the gene and cell therapy field forward requires novel educational approaches and methods
that integrate these disciplines. With small molecule and protein therapies well-established in the
pharmaceutical and biotechnology industries, gene and cell therapy represent the next generation of
therapeutics to address serious unmet medical need. Because these therapeutics involve the delivery of DNA
– in the form of genes or entire genomes – they have the potential to provide long-term therapeutic benefit
following a single administration. However, the gene and cell therapy field face complex biological and
technological challenges. Delivery of genetic constructs, either in vitro or in vivo, must be improved, and in
addition therapeutic payloads including CRISPR/Cas9 and other genome editing machinery requires improved
potency. In addition, cellular targets including human embryonic stem cells (hESCs), induced pluripotent stem
cells (iPSCs), and adult stem cells are difficult to precisely control, since the repertoire of signals and cues that
naturally control stem cell self-renewal and differentiation are not well understood, yet precise control is
essential to unlocking applications in tissue engineering and regenerative medicine. The University of
California at Berkeley has developed the highly interdisciplinary Biology and Biotechnology of Cell and
Gene Therapy (BBCGT) Training Program. With the involvement and support of our 24 faculty, the Berkeley
Stem Cell Center, Bioengineering Department, Molecular and Cell Biology Department, and Helen Wills
Neuroscience Institute, we have designed and have been successfully implementing a program to support the
education and training of predoctoral fellows in gene and cell therapy. This newly emerging discipline
represents the convergence of the biological and biomedical sciences, physical sciences, engineering, and
ethics. The primary objectives of our program have therefore been to formally organize the structure and scope
of new training opportunities in this rapidly expanding discipline, to dissolve traditional academic barriers to
interdisciplinary graduate science education, and to provide strong research training in academia and industry.
As part of these efforts, we will immerse trainees in a Biology and Biotechnology of Cell and Gene Therapy
curriculum, training in the responsible conduct of research, seminar series, annual retreat, interdisciplinary
research, career development resources, industrial internship experience, and participation in a recruitment
and retention plan to enhance diversity. The resulting program will be highly effective in training young
scientists to work at the interface of the biomedical sciences and engineering in a rapidly-evolving, impactful,
and timely area of biomedical research.

Public health relevance
Project Narrative Gene and cell therapy – including gene therapy for rare or complex disease, genome editing, cell replacement, and tissue engineering – is emerging as the next generation of therapeutics to address unmet medical need, and their investigation is also enabling basic investigation of human development and modeling of human disease. Scientists with interdisciplinary backgrounds in biology and engineering are needed to rapidly advance this field. To address this need, the primary objective of this Biology and Biotechnology of Gene and Cell Therapy (BBGCT) Training Program is to provide a structured, supportive, diverse, and interdisciplinary classroom and research training opportunity in our rapidly emerging and expanding discipline.